Immune Function in Sepsis: Role of Sirtuin

Decades long effort to translate pre-clinical research into treatments have failed; there are no effective
molecular-targeted therapies to treat sepsis. Substantial progress in supportive treatments with fluid
resuscitation, timely antibiotics have decreased acute-phase mortality but now a significant proportion
of sepsis and septic shock victims develop, chronic critical illness (CCI). During CCI, the long term
mortality increases from secondary infections and cardiovascular causes. Predicting ultimate fate of
sepsis patients, survival versus death or CCI and ability to respond to secondary infections is difficult.
Immune response in sepsis undergoes a dynamic reprogramming from hyper-inflammation with
immune resistance of pathogen that gives way to a hypo-inflammatory response with immune
tolerance, within hours/days. Leukocyte adhesion, earliest in vivo inflammatory response, is
instrumental to the “resistance” vs. “tolerance” and serves as a “window” to the host immune response.
Sirtuins (SIRTs), a highly conserved family or proteins regulate the shift from hyper- to hypo-
inflammation, including leukocyte adhesion in rodent sepsis. This project will focus on two basic
strategies in to identify the hyper- vs. hypo-inflammatory phase and treat in a phase-specific manner.
Project 1: Establish temporal based physiological marker and biomarkers to distinguish
sepsis phases (GAP 1): Under this aim, we will establish: 1) A rapid in vitro assay of leukocyte
(peripheral blood mononuclear cells: PBMC) adhesion response to secondary stimuli and 2) SIRT1 and
SIRT2 as biomarkers, to identify hypo-inflammatory phase of sepsis. We will study adhesion response
and SIRT biomarker profile during sepsis/septic shock progression in each patients at least at three
different time points and correlate the profile changes with clinical outcomes.
Project 2: Determine the effect of temporal based phase-specific modulations of SIRT1
and 2 on response to secondary stimuli (Gap 2): Using patient PBMCs (monocytes) at different
time points during sepsis/septic shock progression and treating with SIRT1 and SIRT 2
activation/inhibition with genetic and pharmacological approaches, I will study the effect of SIRT
modulation on: 1) Monocyte-endothelial cell adhesion response to secondary stimuli, 2) Immune
response and 3) Bioenergy and metabolic responses during sepsis progression.
Impact: The completion of these studies will 1) Identify markers/biomarkers to identify sepsis phases,
2) Correlate the immuno-metabolic response profile of PBMCs during sepsis progression and patient
outcomes, 3) Identify SIRTs 1 and 2 (and potentially other metabolic/inflammatory molecules) as
phase-specific therapeutic agents.

Public health relevance
Project Narrative Sepsis and septic shock are the leading causes of death in the intensive care units globally. The hyper- inflammatory phase of sepsis gives way to a hypo-inflammatory phase. It is currently difficult to distinguish the phases clinically, and we will develop markers/biomarkers to identify phases and phase-specific therapies.